Improved Detection of Prostate Cancer with Nanoparticle-based Ultrasound Contrast Agents Targeted to PSMA

PROJECT SUMMARY
This competitive renewal application focuses on continued development of cancer cell-specific nanobubble (NB) ultrasound
contrast agents for real-time guidance of prostate biopsies using transrectal ultrasound (TRUS). In the current clinical
workflow, prostate cancer (PCa) biopsies are almost always performed using TRUS guidance. However due to poor soft
tissue contrast of the B-mode ultrasound scans, the delineation of tumors within the prostate using TRUS is not clear.
Because only 1% of the prostate tissue is sampled with a typical 8-12 core biopsy, a lack of direct guidance of the biopsy to
suspicious lesions has led to high false negative rates and rising morbidity from current standard of care. The development
of a new tool to accurately depict cancer within the prostate in real-time using TRUS is thus urgently needed to aid
in biopsy guidance. To provide a practical tool for clear identification of potential malignancies during prostate biopsies,
we have developed a nanoparticle-based ultrasound contrast agent (called a nanobubble) targeted to the prostate specific
membrane antigen (PSMA) which is significantly over-expressed in most prostate cancers. The PSMA-NBs, are similar in
structure to clinically used microbubbles (MB) and are clearly visible on clinical US. In contrast to MB, which remain in
the vasculature, the small size, deformable shell and gas core, enable NBs extravasate and directly bind to cancer cells. This
results in highly specific accumulation of contrast at the tumor itself leading to better resolution and detection of PCa.
During our initial award, we developed an entirely new platform NB formulation which has been rigorously vetted
and tested extensively in animal models of PCa. The objective of the next phase of research proposed in this renewal is to
continue working toward clinical translation by performing IND-enabling studies. Here, we will scale up the NB
formulation, test batch-to-batch reproducibility, conduct toxicology studies and engineer viable long-term storage
techniques. Concurrently we will develop multiparametric US imaging biomarkers unique to NBs and acquisition pulse
sequences optimized for use with the NBs to further enhance the sensitivity and specificity of the PSMA-NB technology;
there are currently no NB specific image acquisition or processing tools for contrast enhanced ultrasound. We will
then test the sensitivity and specificity of PSMA-NB enabled TRUS biopsies in a large animal model of prostate cancer in
dogs, which can accommodate clinical TRUS transducers and a near-identical workflow to clinical standard of care. These
steps are critical to the advancement of the proposed imaging techniques to clinical use. The proposed research feasibility
is supported by strong preliminary data generated by an integrated research team with complementary expertise in NB
formulation and PSMA (Exner, Basilion), bubble-US interactions (Kolios), image processing (Wilson), and clinical prostate
imaging (Bittencourt). The project outcomes will benefit diagnosis, biopsy, and care of prostate cancer using TRUS and
complement the existing clinical workflow.

Public health relevance
PROJECT RELEVANCE The proposed project will continue the development of prostate cancer cell-targeted ultrasound contrast agents, called nanobubbles, which will be used to guide prostate biopsies under transrectal ultrasound (TRUS) imaging. Successfully developed nanobubbles will depict the pattern of primary tumor within or outside the prostate gland and inform planning for biopsy and surgical approaches. In turn, improved biopsies will lead to increased detection of high grade tumors and tumor staging, and lower morbidity.